Cell Biology Core

The goal of the Cell Biology Core is to facilitate research in individual Projects and to foster collaborative studies by providing specialized facilities(e.g., incubators, hoods, workstations, storage facilities, microtome and microscopes (histology), bioreactor) and material and technical support to all of the Projects. .This core unit represents a continuation of the Cell Culture Core from the last grant period. It has been renamed to reflect the broader array of services it provides to the Program. We intend this core unit to operate under the same organizational structure as in the previous grant period.